A Unique Automated Bioreactor for Rearing Aseptic Mosquitoes from Larvae to Adults to Support Manufacture of Sanaria PfSPZ Products

PROJECT ABSTRACT:
According to the World Health Organization, the 228 million cases of malaria in 2018 were an increase of ~16
million cases over 2015 while the number of deaths was 405,000, not substantially less than in 2015. The
world needs a malaria vaccine. Sanaria’s Plasmodium falciparum sporozoite (PfSPZ) vaccines have protected
100% of subjects against controlled human malaria infection (CHMI) in five clinical trials in the U.S., Germany,
Tanzania, and Mali; protected adults for at least 18 months against intense, heterogeneous transmission of Pf
in clinical trials in Burkina Faso, and have been assessed in clinical trials in 6 African and 2 European
countries, and 5 sites in the US in 5 month to 65 year olds. Sanaria has moved to Phase 3 GMP compliant
manufacturing, and is moving toward licensure and commercialization of Sanaria® PfSPZ Vaccine. To
manufacture enough PfSPZ Vaccine to meet the needs of the extensive world markets, particularly those in
Africa, at affordable prices, the scale of manufacturing must be greatly increased and cost of goods (COGs)
reduced. Sanaria’s PfSPZ-based vaccines contain aseptic, purified, cryopreserved, live PfSPZ that are
manufactured in aseptically reared Anopheles stephensi mosquitoes. The current method of infected, aseptic,
mosquito production relies heavily upon human power and large quantities of expensive consumables, and
requires significant space. The overarching aim of this application is to design, build, test and refine a semi-
automated mosquito bioreactor, which will enable hands-free harvesting of aseptic, PfSPZ-infected, adult A.
stephensi and transfer of PfSPZ-infected mosquitoes to an Infected Mosquito Transfer Container (IMTC) ready
for irradiation and dissection, significantly reducing upstream manufacturing costs of PfSPZ products. During
this Phase II SBIR we will finalize a system for semi-automated, closed-system production of aseptic
mosquitoes from eggs through to infected adults ready for irradiation. The specific aims are: 1) Redesign the
larval bioreactor for hands-free, aseptic culturing from eggs to larvae to adult mosquitoes; 2) Redesign adult
mosquito container part 1: direct transfer of adults from the larval bioreactor; 3) Redesign adult mosquito
container part 2: semi-automated transfer of infected mosquitoes to the Infected Mosquito Transfer Container;
4) Redesign the Infected Mosquito Transfer Container for hands free transfer and re-use; and 5) Integrate all
steps and demonstrate their utility for manufacturing in an engineering run of PfSPZ Challenge. Developing
this bioreactor will lead to a sea change in Sanaria’s capacity to manufacture its PfSPZ products, putting
Sanaria on track for robust, mass-scale manufacturing at phase 3 GMP compliance at a significantly reduced
cost.

Public health relevance
PROJECT NARRATIVE: Malaria afflicts over two billion people and kills over 400,000 individuals each year, mostly children in Africa. A powerful tool is needed for eliminating Plasmodium falciparum (Pf) malaria from defined geographical areas and for protecting travelers to malaria endemic regions. The ideal tool would be a highly effective, long-acting vaccine that prevents infection, disease and parasite transmission. Both Pf sporozoite (SPZ) Vaccine (PfSPZ Vaccine) and PfSPZ chemoprophylaxis vaccine (PfSPZ-CVac) provide durable 100% protective immunity against controlled human malaria infection (CHMI) and genetically diverse parasite populations in natural settings. As PfSPZ Vaccine moves into phase 3 and launch, the manufacturing process must be greatly scaled up. Both PfSPZ Vaccine and PfSPZ-CVac are manufactured in aseptically reared mosquitoes. This proposal aims to develop a unique bioreactor system that will support the aseptic rearing of mosquitoes in a hands-free, semi- automated unit from mosquito eggs through to infected adult female mosquitoes ready for dissection. Success in this project will allow massive scale up of mosquito production, currently a labor intensive component of manufacturing, in support of the production of PfSPZ vaccines, and simultaneously greatly reduce cost of goods.